FETAL URINE PRODUCTION &SWALLOWING RATES--CORRELATION WITH AMNIOTIC FLUID

To correlate fetal urine volume and fetal swallowing with amniotic fluid volume in healthy and fluid aberrent (polyhydramionic and oligohydramionic) pregnancies. To determine the pattern of newborn voiding following pregnancies with abnormal amniotic fluid volumes.